NKCC1-KCC2 system modulation in rodent models relevant for psychiatric disorders

Summary
Excitation/inhibition imbalance is considered a major factor leading to cognitive impairment and social
interaction deficits in neurodevelopmental disorders (e.g. schizophrenia), yet the cellular mechanisms
underlying this imbalance are not fully established. Using subchronic phencyclidine (scPCP)-treated mice, a
pharmacological model of cognitive impairment associated with schizophrenia, we discovered that GABAA
function shifts from inhibitory to excitatory in pyramidal neurons of the medial prefrontal cortex of scPCP mice.
We further found that this shift is caused by the selective enhancement of the expression of the chloride
transporter NKCC1, and that NKCC1 antagonism using the NKKC1 inhibitor bumetanide completely restores
the GABAA current reversal potential to the control values. Importantly, we also showed that in-vivo treatment
with bumetanide (IP or local cortical infusion) rescues cognitive performance in scPCP mice. Our preliminary
data further validate these results, showing that bumetanide rescues cognitive performance in male 16p11.2
duplication mice, a genetic model relevant for schizophrenia. We hypothesize that depolarizing GABAA
signaling in the mPFC represents a convergent pathogenic mechanism causing impaired cognition across
multiple genetic models relevant to schizophrenia and that bumetanide treatment may be effective across all
these models. To test this hypothesis, we will take advantage of three etiologically different genetic mouse
models reflecting variable genetic risk for schizophrenia: a copy number variant model (16p11.2 duplication), a
rare variants model (TRIO+/-), and a common variant model (Cacna1C+/-). These models were developed to
mimic genetic conditions known to significantly increase the incidence of psychiatric disorders including
schizophrenia in humans and show numerous deficits in PFC-specific cognitive tasks such as working memory
and reversal learning. In Aim 1 we will use perforated patch recordings in acute cortical slices to determine the
reversal potential of the GABAA current in pyramidal cells of the mPFC, and quantitative in situ hybridization to
quantify expression of NKCC1 and KCC2 transcripts in mPFC from male and female mice. In Aim 2 we will use
behavioral assessment of wild-type mice in which mPFC NKCC1/KCC2 is increased using pharmacologic or
genetic tools to test the hypothesis that increased mPFC NKCC1/KCC2 is a condition sufficient to cause
cognitive impairment, even in the absence of other cellular dysfunctions. We will also the effects of this
manipulation on mPFC gene expression and morphology. Finally, in Aim 3, we will determine the behavioral
effects of NKCC1 inhibition in our three disease models. We will test the effects of acute and chronic treatment
with bumetanide, as well as of selective genetic alteration of the NKCC1/KCC2 ratio in the mPFC of these
mice, on several cognitive tests. We will also test the alternative hypothesis that bumetanide acts on glia rather
than neuronal cells. Successful completion of our experiments may have important translational relevance as
bumetanide is an FDA-approved drug and thus could be immediately tested in clinical trials.

Public health relevance
Narrative While current pharmacological treatments with antipsychotics have beneficial effects on the positive symptoms of schizophrenia, they lack efficacy against cognitive symptoms, which are critical predictors of long-term clinical outcomes. We hypothesize that a shift from inhibitory to excitatory GABAA current in the prefrontal cortex of adult animals is a critical pathogenic mechanism shared by multiple genetic models of schizophrenia representing diverse etiologies including copy number variants (16p11.2 duplication), rare variants (TRIO+/-), and common variants (Cacna1C+/-), and that pharmacological correction of this shift rescues cognitive performance in these animals.